CLINICAL AND LAB INVESTIGATION OF CENTRAL NERVOUS SYSTEM VASCULAR DISORDERS

Endothelial-derived relaxation factor nitric oxide (NO) was shown to mediate autoregulation and chemoregulation of cerebral blood flow. NO synthase (NOS) immunoreactivity was demonstrated in the nerve plexus in the adventitia of the circle of Willis in primates. In a primate model of subarachnoid hemorrhage (SAH) adventitial disappeared on day 7 with the development vasospasm and did not return on day 14 with resolution of vasospasm, suggesting that NO loss plays a central role in the pathogenesis of cerebral vasospasm after SAH. Thus, direct replacement of NO should reverse the vasospastic effect of any NO loss. In the primate model of vasospasm, intra-arterial infusions of NO solution and NO donor solution reversed arteriographic cerebral vasospasm, significantly increased cerebral blood flow, and decreased cerebral blood flow velocity. These findings further support a central role of NO in the pathogenesis of cerebral vasospasm and suggest the potential of a regional NO therapy for cerebral vasospasm. We have explored the effects of the putative agents of vasospasm, oxyhemoglobin and its breakdown product methemoglobin in cell culture. These cultures studies are used to examine the possibility that vasospastic agents (e.g., endothelin) may be released from tissues exposed to oxyhemoglobin and methemoglobin. While exposure to hemoglobin does not directly increase endothelin levels, hypoxia, a condition associated with a decrease in cerebral blood flow, does cause dramatic increases in endothelin. This agent may be responsible for the secondary effects associated with vasospasm after SAH. A specific type of cranial dural arteriovenous fistulas was identified and shown to be treated effectively by simple interruption of the intrathecal venous drainage, a much simpler and safer procedure than the surgical procedure previously used to treat these patients.The lasting efficacy of a simple surgical procedure for patients with spinal dural arterovenous fistulas, interruption of the vein cleaning the fistula intradurally, was demonstrated. A new type of tumor associated with VHL syndrome, low grade adenomocarcinoma of the endolymphatic sac, was identified.